Central Nervous System Reprogramming of the Control of Blood Pressure Induced by Early Life Stress

PROJECT 2 SUMMARY
Early life stress (ELS) acts as a strong etiological factor establishing conditions for subsequent stressors to
trigger many psychological and physiological disorders. There is a strong association between adverse childhood
experiences and cardiometabolic pathologies, including hypertension. When studying the role of the central
nervous system (CNS) in the long-term regulation of blood pressure (BP), we discovered that the hypertensive
response can be sensitized by exposure to mild stressors present earlier in life. Both Dr. Pollock’s laboratory
(Project 1) and our laboratory (Project 2) have found that the psychological stress produced by repeated brief
periods of maternal separation of rodent pups from their mothers (MaSep) will produce hypertensive response
sensitization (HTRS). Our studies suggest that CNS inflammatory mechanisms play a key role in inducing and
maintaining HTRS and therefore increased risk for cardiovascular disease. The central hypothesis of Project
2 is that the psychological stress of MaSep produces inflammatory mediators that reprogram the central neural
network controlling sympathetic tone and BP and thereby exacerbates hypertension when new stressors are
encountered in adulthood. Unfortunately, there are critical gaps in our understanding of exactly how ELS acts to
induce the reprogramming of the CNS and maintain HTRS especially when it is expressed by ecologically
relevant stressors such as eating high fat and high salt diets. Furthermore, we do not know what specific
interventions can reverse the effects of ELS. The Specific Aims of Project 2 are designed to address these
issues. Specific Aim 1 studies will determine whether the dietary risk factors of high dietary fat or salt (i.e.,
“second hits”) consumed after weaning exacerbate the hypertensive response in adult MaSep animals. Also,
key brain nuclei controlling sympathetic tone and BP will be analyzed to identify molecular changes mediating
HTRS. Specific Aim 2 will test the role of CNS inflammatory mechanisms in MaSep induction of HTRS and
investigate strategies to reverse the effects of MaSep ELS and produce resilience. Project 2 is conceptually and
technically innovative in that it tests an original hypothesis of how ELS sensitizes the hypertensive response to
elicit frank HT in adults by using an experimental paradigm developed by the Johnson laboratory to separate the
effects of HTRS induction from HTRS expression. Project 2 findings will provide important new information that
will be relevant for directing the interpretation of results from other projects. Projects 1 and 2 enhance one
another by both investigating the role of brain macrophages and inflammation in ELS-specific vascular
dysfunction and HTRS. Project 2 will provide key mechanistic insights to both clinical projects (3 and 4) by
clarifying involvement of dietary metabolites, exercise, and inflammation. New knowledge gained about
mechanisms involved in HTRS will contribute to understanding the etiology and pathogenesis of essential HT
and will provide valuable insights into intervention strategies for preventing high blood pressure.

Public health relevance
PROJECT 2 NARRATIVE The response to hypertension-eliciting stimuli in adults is sensitized by prior exposure to aversive conditions during early life. Evidence indicates that this sensitized response is the result of neuroplasticity in brain pathways controlling the sympathetic nervous system and long-term blood pressure regulation. The proposed studies investigate the mechanisms of postnatal nervous system programming on hypertensive response sensitization.